Micro-and Nano-space Explorations of Health and Disease

nano-space worlds to grades 3-8 students and K-12 teachers and ultimately to bring these worlds to students across Maine and the nation. Starting with macroscopic and multi-sensory observations, the project staff (during phase I) will enhance visual perception of program participants by more than five orders of magnitude using USM microscopy resources including a new Tecnai BioTwin fully digital transmission electron microscope (TEM) with advanced tomography capabilities in the USM Virology and TEM Laboratory which the PI directs. Phase I of the project (years 1 to 3) will emphasize collaboration of biomedical sciences faculty and staff, K-12 participants, and the staff of USM's Southworth Planetarium on curriculum materials and production of visual resources for far-reaching educational outreach. Phase II of the project will focus on dissemination of curricula and other products of the project while expanding outreach efforts throughout Maine and integrating the academic year programs for K-12 teachers into the academic offerings of the Department of Applied Medical Sciences. Project Description Page 7